Translational Core

PROJECT SUMMARY/ABSTRACT – TRANSLATIONAL CORE
We propose to establish a Center of Biomedical Research Excellence (COBRE) in Pharmaceutical Research
and Innovation at the University of Kentucky (UK). CPRI will serve as a comprehensive multidisciplinary center
focused on translational chemical biology [the nexus of chemical biology (the application of chemical biology
principles to develop validated probe/models to advance our understanding of biology) and pharmaceutical
science (the application of pharmaceutical principles to advance leads/materials/devices that address unmet
clinical needs)]. The COBRE will leverage and develop unique translational chemical biology research support
infrastructure/expertise to facilitate junior faculty mentorship and career development, innovative biomedical
research probe/tool/model/materials development and validation, and the early advancement of potential
‘translatable’ assets. Within this context, the CPRI Translational Core will provide key infrastructure and expertise
to support experimental studies central to probe/lead/materials discovery. Under the co-direction of Drs. Markos
Leggas and Jon Thorson, the Core will support assay design, development, validation and implementation; pilot
screening campaigns; a suite of in vitro absorption, distribution, metabolism, excretion and toxicity (ADMET)
assays; and first in animal ADMET/pharmacokinetics (PK) studies. Support in the Core will be tailored toward
specific COBRE project/pilot needs and screening services will also leverage CPRI-exclusive compound
collections (both natural products and synthetics). The Core’s services have been strategically designed to
integrate with, and complement, the support provided by the CPRI Computational Core and the CPRI-affiliated
COBRE for Molecular Medicine Organic Synthesis Core. Together, CPRI’s corresponding fully integrated
research support capabilities and expertise will accelerate innovative, ‘translatable’ transdisciplinary research
and facilitate junior investigator career development.